Identification and modulation of insula to BNST circuit specific afferents in ethanol abstinence

PROJECT SUMMARY I am the lucky father to a joy-filled eleven-month-old son. It is hard to capture the love he has brought into our family’s life, yet his birth has come with additional stressors. Notably, the financial burden on our new family is significant. My wife works full-time to support the family while I complete my training. My extended family does not live in our state, and my wife’s family is back in her home country, meaning we are largely flying solo. Our seclusion from familial support has made reliable and accessible daycare a necessity to my ability to do science. There have been days on which daycare was closed (due to Covid exposure). During that time, my son stayed home, and I became a full-time parent. It proved a stark illustration of how necessary childcare is to my ability to continue working to better understand the neurocircuitry involved in stress and addiction. Unfortunately, even within this year, we have seen childcare costs continue to rise from what already felt barely affordable on a graduate student’s salary. This cost puts significant strain on our budget. Funding for childcare expenses will help us offset those costs and allow me to work more effectively to achieve the project’s original aims.

Public health relevance
PROJECT NARRATIVE Alcoholism is a chronic relapsing disease with significant morbidity, mortality, and associated social and economic costs that continue to rise. Stress during abstinence is often a key contributor to relapse, and understanding the related neurocircuitry (in regions such as the insula and BNST) may provide new avenues for treatment. The research proposed in this grant aims to determine the role of neurons that project from the insula to the BNST in alcohol addiction, identify crucial regulatory inputs to these cells, and ascertain the effect of ethanol and the endocannabinoid system on those afferents.